Metabolic activation of nitroarenes and Nrf2-Keap1

Nitroarenes are carcinogens found in car exhaust and prominent in diesel exhaust. They pollute the air we
breathe, contribute to air pollution which is rising due to climate change. Nitroarenes of concern are 1-nitropyrene
(1-NP), 1,8-dinitropyrene (1,8-DNP), 3-nitrobenzanthrone (3-NBA) and 6-nitrochyrsene (6-NC). Nitroarenes
undergo metabolic activation by nitroreduction via a nitroso- and hydroxylamino- intermediate and amine product
and numerous enzymes have been implicated. In the last funding period, we found that prominent
nitroreductases involved in the metabolic activation of 1-NP, 1,8-DNP and 3-NBA in human lung cells were the
aldo-keto reductases AKR1C1-AKR1C3; furthermore, the genes encoding these enzymes were induced by the
NRF2-KEAP1 stress response pathway and genetic knock out of this pathway eliminated nitroarene activation.
These findings were among the first to demonstrate that activation of the NRF2-KEAP1 pathway may be harmful
in the context of nitroarene exposure and could initiate the carcinogenesis process rather than prevent it. In this
renewal we hypothesize that AKR1C enzymes induced by the NRF2-KEAP1 pathway activate nitroarenes
to intermediates that adduct proteins and DNA, with a resultant increase in mutation, that ultimately
leads to increased carcinogenesis. This hypothesis will be tested by using the following human lung cell lines:
A549 (human adenocarcinoma cells with constitutive expression of NRF2 due to hypermethylation and mutation
of KEAP1); A549 cells with NFE2L2/NRF2 heterozygous and homozygous knockout generated by
CRISPR/Cas9, and HBEC3-KT cells (immortalized human bronchial epithelial cells with inducible NRF2). In Aim
1: We will determine whether human AKRs metabolically activate 6-nitrochrysene (6-NC) in the human lung cells
described using both genetic and pharmacological approaches. 6-NC is unique in that it can be activated by
monooxygenation and nitroreduction. We will determine whether human AKR1C enzymes reduce the nitro group
of 6-NC-1,2-DHD to form 6-aminochrysene-1,2-DHD (6-AC-1,2-DHD) on route to DNA adducts or whether their
dihydrodiol dehydrogenase activity will yield a highly reactive 6-nitrochysene-1,2-dione. In Aim 2: We will use a
targeted proteomics approach to determine whether nitrosoarenes generated by AKR1C enzymes adduct
proteins that control redox-state including KEAP1 itself in HBEC3-KT cells. Detection of sulfinamide and
sulfonamide adducts in human lung cells would demonstrate that nitrosoarenes may modify the proteome and
affect tumorigenesis. In Aim 3: We will determine whether the adductome resulting from nitroarene exposure in
A549 and HBEC3-KT cells is NRF2 dependent. Covalent and oxidatively damaged DNA adducts will be
measured by stable-isotope dilution liquid chromatography mass spectrometry. In Aim 4: We will determine for
the first time if AKR1C enzymes increase the mutagenicity of nitroarenes on the HPRT gene. We will determine
the mutation frequency, potency, pattern, spectrum, and signature and whether the distribution of single base
substitutions is similar to COSMIC (catalog of somatic mutations in cancer) observed in human cancers.

Public health relevance
Narrative Air pollution will increase because of climate change. Its particulate phase contains nitroarenes that arise from car and diesel exhaust and may contribute to lung cancer. We will show that a major stress response pathway leads to nitroarene activation with resultant modifications in proteins and DNA that lead to mutation. Measurement of these changes will increase exposure assessment and lead to improved biomonitoring and lung cancer prevention.